Administrative Core

Administrative Core
SUMMARY
The Administrative Core of the Center for Tumor-Immune Systems Biology will work collectively to support and
accomplish the proposed goals of the center. The administrative core will provide the organizational support and
leadership to the Research Projects, Shared Resource Core and Outreach Core to accomplish their goals and
disseminate the accomplishments of each Project and Research Center lab to all Research Center investigators
and the scientific community at large. The Research Center Administration will also serve as the nexus for
Research Center communication, provide budgetary review and scientific oversight, and fulfill reporting
requirements to the NCI. The leadership team of the multiple PIs, Drs. Christina Leslie and Alexander Rudensky,
will oversee the research teams and the shared resource, administrative and outreach cores. The Scientific
Director (Dr. Lalitha Ramanthapuram) and Data Manager (Dr. Tal Nawy) will work with the core leaders to fulfill
the administrative, project management and data management responsibilities of the center.